Elucidating the mechanisms of non-canonical CDK8 function in DNA damage signaling

PROJECT SUMMARY
The Mediator of transcription is a multi-subunit protein complex that is a critical component of RNA polymerase
II-mediated transcriptional machinery which regulates the transcription of essentially all genes. The core
Mediator contains a head, middle and tail module, and an accessory kinase module (CKM) which can reversibly
associate with the core Mediator. CKM-bound core Mediator has generally an antagonizing effect on
transcription; however, it can selectively to promote the transcription of specific transcripts in certain contexts. In
addition to its opposing effects on transcription, CKM influences a variety of cellular processes including stress
responses, genome organization and tumorigenesis. However, it is not well-understood how CKM incorporates
signals from these divergent pathways, and whether these functions of CKM are dependent on its kinase activity
and its interactions with core Mediator. Through a genome wide unbiased interaction screen in yeast to identify
novel pathways that contribute to the regulation of DNA damage response, an intricate signaling pathway
involved in protecting the integrity of the genome, I discovered an intriguing genetic interaction with the Mediator.
Through a focused mutational screen of Mediator-CKM subunits in yeast, I found that all of the four CKM subunits
as well as CKM’s kinase activity are essential for cell cycle re-entry following a DNA break. Notably, the CKM
mutants did not impair UV damage repair or DNA double-strand break repair through homologous recombination,
indicating that CKM specifically impinges on DNA damage response. Furthermore, I demonstrated that CKM
contributes to the global downregulation of transcription following DNA damage. To address the crosstalk
between CKM and DNA damage signaling and uncover fundamental aspects of CKM regulation, in Aim 1, I will
ask if CKM directly interacts with DNA damage factors in yeast and mammalian cells by immunostaining, live
cell imaging and immunoprecipitation. I will ask whether the proteins in DNA damage response pathway are
direct targets of CKM’s kinase activity by employing phosphoproteomic mass spectrometry analyses. In Aim 2,
I will examine how the DNA damage response alters CKM function, focusing on its subunit composition, kinase
activity and substrate scope, and genome-wide localization by using a combination of in vivo and in vitro
approaches. Lastly, in Aim 3 will focus on the transcriptional aspect of CKM and DNA damage crosstalk in yeast;
specifically, the DNA damage- and CKM-dependent downregulation of histone transcripts. I will ask whether this
downregulation leads to global nucleosome depletion and increased chromatin mobility to promote homology
searching by using internally-calibrated chromatin immunoprecipitation and live cell imaging of DNA break
movement. These studies will reveal the molecular mechanisms of previously uncharacterized link between DNA
damage and CKM while addressing long-standing questions on CKM modulation.

Public health relevance
PROJECT NARRATIVE DNA damage response is the first line of defense to protect genomic integrity; hence, dysregulation of the DNA damage response leads to accumulation of mutations as well as diseases including cancer; neurodegenerative diseases such as Alzheimer’s, Parkinson’s and ALS; and several types of ataxia. Our preliminary data reveal a surprising and previously uncharacterized link between DNA damage and the kinase module of the Mediator of transcription, a protein complex which is also shown to contribute to tumorigenesis. This research proposal will investigate this link and provide mechanistical insights into the regulation of DNA damage response by the kinase module of the Mediator.